16th Biennial Meeting of the Diabetes in Pregnancy Study Group of North America

Project Summary The 16th biennial meeting of the Diabetes in Pregnancy Study Group of North America (DPSG-NA) will be held on October 31-November 1, 2019 at the Intercontinental-The Wharf in Washington, DC. This 1.5 day meeting focuses on research which addresses the specialized needs of pregnant women with type 1, type 2, and gestational diabetes mellitus. Since its inception, the DPSG-NA meetings have become a vehicle for the dissemination of data, gathered through collaboration among basic, translational, and clinical research and care centers, both in the United States and abroad. The meeting covers a board range of issues related to diabetes in pregnancy, but the focus of the meeting is to highlight major, timely issues in the field. The major goal of this meeting is, and has historically been, to serve as a driving force for discussions and new collaborations that open novel areas of exploration into prevention, treatment and management approaches to reducing the burden of diabetes and its comorbidities on pregnant women and their offspring. This goal will be achieved utilizing oral presentations, roundtable discussions, and debates that will bring together world’s experts, young investigators, students, and trainees who all have a keen interest in the field. The focus of the upcoming meeting will be diabetes care across the continuum of the preconception period, all three trimesters of pregnancy, postpartum and pregnancy interval, and the long-term life of the mother and baby. The program includes a keynote address from a perinatology expert to discuss the strategies to reduce the diabetes epidemic in the United States. Speakers include established experts and young investigators, with about 20% of the meeting time allocated for speaker-conferee discussions. Young investigator presentations are an important aspect of the meeting, and they are an effective tool to help bring a new generation of scientists into our community and foster their maturation by their inclusion as presenters and session chairs. In addition, a dedicated poster session will be enhanced by holding an evening reception in the poster room to ensure information discussions among conferees. Formal presentations and informal discussions among conferees are highlights of this unique meeting that fosters a collaborative, multifaceted approach to improving the health and wellbeing of pregnant women with diabetes and their offspring.

Public health relevance
Project Narrative The major goal of this meeting is to serve as a forum for discussions about cutting-edge research aimed to improve the prevention, management and treatment of diabetes in pregnancy. This meeting brings together national and international experts, practitioners, nurses, diabetes educators, junior faculty, fellows and students to participate in formal presentations and informal discussions. The 16th biennial meeting has a strong emphasis on participation by women, young investigators, and fellows. This unique meeting has a long history of addressing controversial topics and to develop new strategies to improve the health and wellbeing of pregnant women with diabetes and their offspring.